Accelerated Neuromodulation of Prefrontal Circuitry during Clozapine Treatment

PROJECT SUMMARY
Schizophrenia is associated with significant morbidity and mortality across the world, largely due to poor
functional outcomes driven by cognitive impairments. Treatment-resistant schizophrenia (TRS), a more severe
manifestation of the syndrome, is associated with worse functional outcomes and disproportionately higher
individual and socioeconomic burden. Treatment options typically consist of psychosocial interventions and
clozapine (CLZ), which remains the sole pharmacologic agent that has demonstrated a unique efficacy for
TRS. However, even after success with CLZ, the cognitive deficits and global impairments that limit daily social
and vocational functioning remain in most individuals. Thus, there is an urgent need for additional strategies
that address the cognitive deficits and the biological complexity associated with TRS. A core cognitive deficit
often linked with functional outcomes in schizophrenia is working memory (WM). Our recent work, focused on
longitudinal CLZ treatment for TRS, showed that higher WM performance correlates with a greater post-
treatment anticorrelation between the dorsolateral prefrontal cortex (DLPFC) and the cholinergic basal
forebrain (BF). Critically, this functional circuit overlaps with connectivity findings associated with transcranial
magnetic stimulation for major depressive disorder. Recent work has advanced a more efficacious method for
transcranial magnetic stimulation that utilizes a connectivity-based, accelerated intermittent theta burst
stimulation (iTBS) protocol for treatment-resistant depression. Studies with similar methods suggest that
DLPFC stimulation may enhance WM performance. Given the crucial need for WM enhancement in TRS, and
based on our work with CLZ, we will adopt this accelerated iTBS method to target DPLFC-BF functional
connectivity. In a within-subject, randomized, crossover design, individuals with TRS receiving CLZ treatment
will complete sessions of both accelerated iTBS and sham stimulation. Participants will undergo fMRI scanning
at rest and while performing a WM task at baseline and immediately after both iTBS and sham stimulation.
We will examine whether accelerated iTBS results in: (1) greater DLPFC-BF anticorrelation, and (2) increased
WM activation and performance. We will also explore whether CLZ/norclozapine ratios, which characterize
cholinergic contributions to treatment, relate both to connectivity and WM activation or performance following
accelerated iTBS delivery. Consistent with goals of the NIMH Strategic Plan, our proposal will collect critical
preliminary data that will lay the foundation for a larger mechanistic trial focused on WM enhancement in TRS
within CLZ’s robust pharmacologic setting.

Public health relevance
PROJECT NARRATIVE While clozapine consistently demonstrates a superior benefit for treatment-resistant schizophrenia, treatment strategies for cognitive deficits of the condition remain limited, warranting a more comprehensive approach. In this study, we will apply a novel method for transcranial magnetic stimulation to examine whether it enhances neurocognition and prefrontal cortex circuitry in a cohort of individuals with treatment-resistant schizophrenia receiving clozapine treatment. Results from this preliminary work will lay the foundation for a larger treatment trial focused on optimizing care for treatment-resistant schizophrenia.